Harnessing a Two-State FEP LHS to Optimize Engagement and Prevent Disengagement in CSC

Overall Component - Abstract
This Program Project Grant entitled Harnessing a Two-State FEP LHS to Optimize Engagement and Prevent
Disengagement in CSC will leverage Connection Learning Healthcare System (CLHS) - a two-state learning healthcare
system and Early Psychosis Intervention Network (EPINET) hub (MH120550, Bennett PI) - to pursue integrated
research and knowledge generation focused on optimizing Coordinated Specialty Care (CSC) engagement and
preventing disengagement in youth with first episode psychosis (FEP). CLHS has a demonstrated track record of
collecting, managing, and analyzing data from the EPINET Core Assessment Battery (CAB) from 23 CSC programs
across Pennsylvania and Maryland. The close collaboration and combined expertise of investigators from the University
of Maryland, the University of Pennsylvania, Johns Hopkins University, the University of Pittsburgh, and Sheppard Pratt
Healthcare has supported practice-based data collection, hub-centered data analysis, and translation of data to practice
through learning healthcare and culture building initiatives. The group of investigators has internationally renowned
experience in research on schizophrenia, FEP, and CSC implementation, as well as in psychiatric services research,
interventions development and implementation in psychosis, cognition and cognitive assessment; neuroimaging and
brain functioning in schizophrenia, clinical trials, implementation science, psychopharmacology, culturally competent
clinical care, participatory, and peer services research. This consortium has interacted and in a superbly collaborative
manner sharing technical and scientific information through formal monthly face-to-face or Zoom-based meetings,
frequent telephone or electronic communication and across-campus visits. This offers tremendous opportunities for in-
depth study of disengagement risk and of strategies that can prevent it. The Administrative Core will build on the
infrastructure of CLHS to support two well-specified research projects and to foster additional research, knowledge
generation, and quality improvement initiatives focused on preventing CSC disengagement by providing services in
data collection, management, and analysis; supporting learning healthcare system activities that integrate CSC program
ideas into research development; and fostering involvement of participants with lived experience of psychosis and family
members to make research on disengagement responsive to the experiences of people who are directly impacted by
CSC. The Clinical Practice Data Research Project will use CLHS CAB data to develop and validate longitudinal models
for predicting risk of CSC disengagement and to integrate stakeholder input on the clinical utility of using risk information
in clinical practice. The Prospective Practice-Oriented Research Project to develop a hub-based engagement navigator
service for supporting participants and families at high risk for disengagement. We will use robust participatory research
methods to ensure the integration of CSC program staff, participants, and family members in the development of all
aspects of and materials for the navigator service and conduct a mixed methods hub wide ENS evaluation using a
hybrid type I open cohort stepped wedge design to examine feasibility, acceptability, and effectiveness in changing target
mechanisms and improving disengagement outcomes.

Public health relevance
Overall - Project Narrative This project will use a learning healthcare system research framework to (1) develop and validate models for predicting Coordinated Specialty Care disengagement augmented by conversations with participants and clinicians to specify how this knowledge can be integrated with clinical practice and (2) develop and evaluate a centralized referral and intervention navigator service to support participants and families at high risk for disengagement. We will use robust participatory research methods to ensure the integration of CSC program staff, participants, and family members in the development of this service. Five research groups with histories of contributions to FEP/CSC research and clinical practice will collaborate to support these opportunities for in-depth study of disengagement risk and of strategies that can prevent it.